ERC Einstein-Rockefeller-CUNY Center for AIDS Research

Project Summary
The NIH selected the Einstein-Rockefeller-CUNY Center for AIDS Research (ERC-
CFAR) to host the 28th annual meeting of the CFAR network on October 28 – 30,
2024. Located in New York City, the mission of the JHU CFAR is to enhance the
integration and productivity of ERC-CFAR HIV/AIDS research by promoting inter-
disciplinary innovation and collaboration for creating synergy and efficiencies across
disciplines and university divisions and partner institutions. The agenda for the 2024
meeting will focus on interactions between the various CFARs, the National CFAR
Community Advisory Board (CAB) Coalition (N3C) and the NIH. The agenda for the
28thth includes the CFAR administrators meeting and a meeting of the N3C
Executive committee. A Community and scientific symposium will occur on the 29th
and the agenda for the 30th includes the CFAR Director’s meeting and the N3C
business meeting. A mentoring workshop for Early Staged Investigators (ESIs) will
also occur on the 30th. This workshop will provide an opportunity for ESIs to learn
about proposal development, grant funding, and project management from their
colleagues and leading faculty. The overall objective of the annual meeting is to
enhance communication and collaboration across the 19 CFARs. This will be
accomplished through multi-directional meetings focused on highlighting high impact
programs and best practices, important updates from the NIH for CFAR program
guidance, and identifying stakeholder priorities for strategic planning as the CFAR
program evolves.

Public health relevance
Project Narrative It is important to convene CFAR members at the forefront of HIV research, providing a unique opportunity to present recent findings and advances in HIV/AIDS research. Additionally, the meeting is an ideal forum to build on and strengthen collaborative research between senior faculty and ESIs. Inclusion of the National CFAR Community Advisory Board (CAB) Coalition (N3C) offers an opportunity for community stakeholders to be informed of emergent research that will directly impact the wellbeing of their communities, as well as providing feedback to the CFARs as to how to effectively engage with their local communities.